Development and Pilot Evaluation of an Online Intervention to Prevent Dating Violence and Problem Drinking in Sexual Minority Youth

Project Summary (Supplement)
Purpose of the Administrative Supplement: In response to NOT-OD-22-159 (Support Research on Preventive
Interventions with Populations that Experience Health Disparities), the purpose of this administrative
supplement is to support the addition of two aims to further assess the impact of an alcohol use (AU) and teen
dating violence (TDV) online prevention program (PRYSHM [Promoting Resilient Youth with Strong Hearts and
Minds]; formerly entitled R3) for sexual and gender minority youth (SGMY) on SGMY of color. In addition to
evidence-based AU and DSV prevention components (e.g., bystander intervention skills, correcting
misperceptions of social norms, refusal skills), the nine-session PRYSHM program focuses on positive identity
development, coping with stressors related to being a SGMY as well as a racial/ethnic minority youth, and
seeks to instill hope for the future in SGMY, including multiply minoritized SGMY. As such, in this supplement,
we seek to sample an additional 100 SGMY to examine positive ethnic/racial/cultural identity development as a
mediator of program outcomes (e.g., reductions in AU and TDV [primary outcomes] and reductions in
depression, drug use, and sexual risk taking) among SGMY of color (Supplemental Aim 1). We also seek to
ensure that the PRYSHM program is working equally well for SGMY of color by conducting multiple group
models by SGMY race/ethnicity (Supplemental Aim 2). These aims are critically important given we know
essentially nothing about prevention among SGMY of color, although research suggests that universal
prevention programs do not work for SGMY, nor for youth of color. Although efforts are needed at the structural
level to reduce heterosexism, cisgenderism, and racism, and create safe/affirming environments for SGMY,
including SGMY of color, so too are programs that help to build resilience in these youth as a way to reduce
health disparities.

Public health relevance
Project Narrative (Supplement) Dating violence (DV) and alcohol use (AU) occur at alarmingly high rates among SGMY, and minority stress is a unique and critically important risk factor for DV and AU in SGMY, whereas sense of community with other SGMY can serve as a protective factor. The overarching goal of the proposed project is to develop an innovative, online synchronous DV and AU prevention curriculum created specifically for SGMY (ages 15 to 18); conduct a pilot randomized controlled trial to assess feasibility and acceptability of the intervention and study procedures; identify preliminary outcomes of the intervention; and ensure that the intervention is working equally well for SGMY of color. The project focuses on two interrelated and significant public health issues (i.e., DV and AU), proposes an innovative approach to prevent them, and is highly consistent with the Healthy People 2020 goals of reducing violence and substance use and improving the health, safety, and well-being of SGMY including those who are multiply minoritized.